Core A: Administration

SUMMARY
The four dengue virus (DENV1-4) cause the most important arthropod-borne viral disease of humans
worldwide, with up to 100 million cases annually. Since an infection with one serotype can results in immune
responses that can either protect or enhance a subsequent DENV infection with a different serotype, a
comprehensive understanding of the human adaptive immune response to DENV is critical for delineating
immune correlates and devising safe and effective vaccines. In this Program Project (P01), “Protective
immunity following dengue virus natural infections and vaccination”, the Administrative Core (Core A) will be
responsible for coordinating Program Project (P01) partners by providing an umbrella infrastructure that will
manage overall operations. Effective scientific management and coordination by the Administrative Core will
give direction, oversight, and quality assurance for each Project and Core's research activities and will
maximize collaboration and exchange among all participating members. Core A will achieve this by ensuring a
dynamic interaction among all researchers in the Program Project, specifically, by fostering and facilitating the
timely exchange of information, necessary reagents and protocols and sharing of data, and will assume
financial responsibility for the costs associated with these activities. Core A will promote and mediate regular
communication and will facilitate the logistics for scheduled meetings, monthly P01-wide teleconferences, and
ad hoc calls. It will also be responsible for arranging and facilitating an annual in-person meeting at the UC
Berkeley campus where the overall P01 Director, Project 1, Core A, and Core C are headquartered. In
addition, Core A will provide fiscal oversight and general administrative and budgetary support for the overall
Program Project in coordination with all the administrative designees from the partner institutions. Finally, Core
A will coordinate reports to the NIH, ensure compliance with NIH and local institutional requirements, including
an ongoing consortium-wide MTA and serve as the primary contact between the P01, the NIAID program
officer, and other NIAID staff. Thus, Core A plays a central role in ensuring the smooth administrative
functioning of the Program Project as a whole.

Public health relevance
NARRATIVE Dengue is a major public health problem worldwide, and it is critical to improve our understanding of the human immune response to dengue virus infection and what elements of immune response are associated with protection from or susceptibility to disease. This Program Project help define immunological imprinting in sequential dengue virus infections as well as immune correlates of protection and risk, contributing to efforts to develop a safe and effective tetravalent dengue vaccine that confers long-term immunity to all four DENV serotypes. The Administrative Core (Core A) will provide crucial coordination functions to the P01 to ensure regular communications for a fluid exchange of ideas, data, and reagents between P01 investigators as well as compliance with NIH and local institutional requirements.